Dynamic control of vascular permeability in development and disease

PROJECT SUMMARY
The integrity of the vasculature in general and the blood-brain barrier (BBB) in particular, is of critical
importance both for prevention of edema due to inflammation and injury and for targeted treatment of CNS
pathologies. The ability to open BBB “on demand” and to restore its integrity when damaged, has long been a
holy grail for therapeutics. Yet the progress has been slow due to very limited understanding of mechanisms
controlling BBB integrity. Indeed, no drugs currently exist that can regulate vascular permeability or BBB
function. Preliminary studies from our laboratories have identified two novel, druggable pathways that
selectively regulate these processes. We will define molecular basis of these novel permeability-regulating
pathways, determine their biological role and develop and test therapeutic applications based on this
knowledge. In particular, we propose to test a new antibody-based approach to the reduction of brain edema in
acute ischemic stroke and another antibody based approach to on demand increase in the blood-brain barrier
permeability sufficient to allow delivery of drugs to the brain.

Public health relevance
PROJECT NARRATIVE We have identified that a novel and selective control point regulating blood vessel permeability (leakage). This control point can be effectively manipulated to either increase or decrease blood vessel leakiness, including that of the blood-brain barrier. A detailed understanding of this mechanism will allow development of novel therapeutics that can be applied to the treatment of stroke and effective drug delivery to the brain.